Unraveling the neural mechanisms for satiety and weight loss by GLP1-based drugs

PROJECT SUMMARY
Over the last several decades, obesity rates have been rising, and research has failed to solve this public health
crisis. Now, we are at the precipice of change. Glucagon-like peptide-1 (GLP1)-based obesity drugs have
emerged as a promising strategy for weight loss, and their unprecedented success is transforming the treatment
of obesity. Despite their popularity, we have little understanding of the brain mechanisms that drive the food
intake and body weight reduction from these drugs. In our preliminary studies, we found that hindbrain GLP1
receptor (GLP1R)-expressing neurons are necessary and sufficient for the effects of GLP1-based obesity drugs
such as semaglutide (Ozempic®/Wegovy®). Further, our data suggest that the neural circuits that mediate the
food intake suppression and the nausea/aversion (the top side effect of these drugs) are anatomically and
functionally separable. Specifically, we identified a population of nucleus tractus solitarius (NTS) GLP1R neurons
that project to the paraventricular hypothalamus (PVH) that suppresses food intake and body weight without
causing aversion. Building on these data, this proposal will behaviorally, physiologically, anatomically, and
molecularly characterize NTSGLP1RPVH neurons as a potential target for weight loss drugs with fewer side
effects. First, we will test the necessity of NTSGLP1R neurons, their receptors, and their projections to the PVH, in
mediating the satiety and weight loss effects of semaglutide. Next, we will determine the endogenous neural
activity patterns of NTSGLP1R neurons in response to gut-derived signals and obesity drugs, and how this activity
changes in diet-induced obesity. Finally, we will determine the inputs and outputs of NTSGLP1R neurons to map a
circuit for non-aversive satiety. This comprehensive analysis of NTSGLP1RPVH neurons will uncover a novel
neural circuit for feeding behavior, and determine the suitability of this population as a selective target for future
drug development.

Public health relevance
PROJECT NARRATIVE Agonists of the glucagon-like peptide-1 receptor (GLP1R) are the most successful obesity drugs to date, but we lack a mechanistic understanding of how they work in the brain to suppress food intake. Here, we will characterize NTSGLP1RPVH neurons as a target for obesity drugs to reduce food intake and body weight without causing aversive side effects. Results from these studies will guide the development of safer and more effective obesity drugs.